Clinical Evaluation and Risk Stratification of Angle Closure Disease Using Quantitative OCT

Abstract
Glaucoma is the leading cause of irreversible blindness worldwide. Angle closure, which impairs aqueous humor
outflow and leads to elevated intraocular pressure (IOP), is the primary cause of 23 million or nearly one third of
all glaucoma cases. Primary angle closure glaucoma (PACG) is three-fold more visually damaging than primary
open angle glaucoma (POAG), afflicting 6 million people with blindness. While most cases of PACG are
preventable with early intervention, current practice paradigms are severely limited in predicting which patients
with early angle closure, termed narrow angles, will develop PACG. Among key barriers hindering the care of at-
risk patients is reliance on gonioscopy, the current clinical standard for detecting angle closure. Gonioscopy is
subjective, qualitative, expertise-dependent, time-intensive, and uncomfortable. These limitations contribute to
underperformance of gonioscopy by clinicians, delayed detection of PACG, and blindness in a quarter of
diagnosed cases. Some racial groups in the United States are more vulnerable to PACG-related blindness;
Blacks and Hispanics are at 50% and 30% higher risk compared to non-Hispanic Whites. Recent landmark
studies also show that current disease definitions based on gonioscopy are weakly predictive of which patients
will develop PACG; over 100 “at-risk” patients require treatment to prevent a single case of PACG. This limitation
leads to poorly defined practice guidelines and confusion among clinicians regarding prophylactic treatment for
PACG, which, unlike POAG, is largely preventable. Therefore, there is an urgent need for a more convenient
and precise clinical tool to prevent PACG-related blindness and mitigate disparities in disease burden. Anterior
segment OCT (AS-OCT) is a non-contact, reproducible, quantitative alternative to gonioscopy for evaluating the
angle. Our research group have been pioneers in clinical applications of AS-OCT for angle closure. We showed
AS-OCT measurements are predictive of elevated IOP, disease course, and treatment response, whereas
gonioscopy is not. More recently, we developed custom software to automate quantitative analysis of AS-OCT
images, thereby removing the barrier of manual analysis and unlocking the full potential of AS-OCT for clinical
care and scientific research. In this proposal, we seize the momentum of recent research findings and
methodological advances to shift practice paradigms and establish quantitative AS-OCT as the new clinical
standard for evaluating and risk-stratifying patients for PACG. Specifically, we will: 1) elucidate the anatomical
basis of disparities in angle closure using biometric data from a large multi-racial cohort; 2) establish quantitative
OCT-based definitions of narrow angles based on 3-year risk of elevated IOP and PACG; 3) identify novel
dynamic biometric risk factors to predict disease outcomes. Our proposed studies will address urgent needs by
clinicians for fundamental knowledge about disparities in angle closure disease and precise tools for delivering
care to patients at risk for PACG. Ultimately, these studies will help clinicians prevent PACG-related vision loss,
mitigate disparities in disease burden, and optimize utilization of healthcare resources.

Public health relevance
Project Narrative Primary angle closure glaucoma (PACG), a leading cause of irreversible vision loss worldwide, is more visually damaging but also more preventable than other common types of glaucoma. Gonioscopy, the current clinical standard for detecting patients at risk for PACG, is ineffective and inconvenient for doctors to use, which contributes to poorly defined practice guidelines, delayed disease detection and treatment, and high prevalence of blindness. We propose to establish anterior segment OCT (AS-OCT), a convenient and precise form of ocular imaging, as the new clinical standard to detect and evaluate individuals at risk for PACG and reduce PACG- related vision loss.